Immunomodulation of juvenile femoral head osteonecrosis

Project Summary
Legg-Calvé-Perthes disease is a childhood ischemic osteonecrosis of the femoral head (ONFH) that affects 1 in
1200 children between the ages of 2 to 14. It is one of the most serious conditions affecting the pediatric hip as
50% of patients will develop debilitating osteoarthritis, some in their teenage years. A disruption of blood flow
produces extensive ischemic cell death, abundance of necrotic cell debris, and damage-associated molecular
patterns (DAMPs) in the femoral head. We discovered that the necrotic microenvironment incites a chronic
inflammatory response, which impairs bone regeneration and produces femoral head deformity. Macrophages
are the central innate immune cells that coordinate the repair process based on local environmental stimuli. In
juvenile ONFH, macrophages exhibit chronic inflammatory response due to DAMPs and necrotic debris which
leads to further tissue damage and fibrosis. Current treatments do not address the negative pathologic role
played by macrophages in the necrotic bone repair. Here, we propose a new concept of reconditioning the
necrotic bone using minimally invasive tissue engineering methods, thereby, converting a necrotic inflammatory
microenvironment to a regenerative microenvironment. Our long-term goal is to establish these treatment
methods to overcome the substantial inflammatory roadblock and to rapidly recondition the necrotic bone in
order to jump start bone regeneration in patients with juvenile ONFH. Our central hypothesis is that the necrotic
bone microenvironment triggers chronic inflammatory macrophage response, and that tissue engineering of the
necrotic environment by local bone wash (i.e. clearance of DAMPs and necrotic debris) and application of
macrophage-directional modulators (such as bone morphogenetic protein-2 and interleukin-4) will increase pro-
healing macrophages and accelerate bone regeneration. We will attain our goal through three highly related but
independent specific aims. We will 1) determine the therapeutic effects of washing out DAMPs and necrotic cell
debris on macrophage response; 2) determine the effects of macrophage response to local controlled-release
bone morphogenetic protein-2 (BMP2) therapy using a hydrogel delivery system on bone regeneration; and 3)
determine the role of interleukin 4-induced macrophage modulation on bone regeneration, using the piglet model
of ischemic ONFH and in vitro experiments in each Aim. We will determine the macrophage and bone repair
responses to the immunomodulatory therapies using tissue, cell, and RNA analytic methods. Successful
completion of this project will have immediate clinical impact by providing a proof-of-concept for the minimally
invasive, yet potentially highly effective, tissue engineering strategies to overcome current barriers to successful
treatment of ONFH. The outcome of this work will lay the groundwork for clinical trials and will greatly advance
our ability to treat ONFH using immunomodulatory strategies.

Public health relevance
Project Narrative Legg-Calvé-Perthes disease is one of the most serious conditions affecting the pediatric hip as 50% of patients will develop debilitating osteoarthritis. The project will develop new necrotic bone reconditioning and immunomodulatory treatments to target chronic inflammatory macrophage response that hinders bone regeneration in this hip disorder. Successful completion of this project will have immediate clinical impact by providing a proof-of-concept for the minimally invasive, yet potentially highly effective, tissue engineering strategies to overcome current barriers to successful bone regeneration in Legg-Calvé-Perthes disease.